Photosensory LOV proteins: Study and application of signaling mechanisms

Field 7-Project Summary PLACEHOLDER PA-18-591 says section 7 to should also be included if there are changes by the proposed supplement activities. Although there are no changes, a document is required per Grants.gov instructions.

Public health relevance
Field 8-Project Narrative PLACEHOLDER PA-18-591 says section 8 to should also be included if there are changes by the proposed supplement activities. Although there are no changes, a document is required per Grants.gov instructions.